Investigating the Role of High Fat Diet in Hematopoiesis and Clonal Hematopoiesis

PROJECT SUMMARY: Aging of the hematopoietic system is accompanied by increase in proliferation but
functional decline of hematopoietic stem cells (HSCs), which often exhibit a bias towards myeloid lineage
differentiation. These changes are thought to be clinically significant, contributing to age-associated declines in
immune function in the elderly. It has been recently discovered that some aged HSCs accumulate somatic
mutations that are commonly found in myeloid malignancies. HSCs and progenitors (HSPCs) with these
mutations exhibit increased contribution to the blood, a condition termed clonal hematopoiesis (CH). Somatic
mutations in CH are recurrently found in about 20 genes, with DNMT3A, TET2 and ASXL1 the top three genes
most frequently seen in patients. In clonal hematopoiesis of indeterminate potential (CHIP), a clonal, somatic
mutation that is associated with myeloid malignancies is detectable in the peripheral blood at a variant allele
fraction of at least 2%. CHIP mutations are found in about 10% of people who are 65 or older but have no obvious
signs of blood disease, and the incidence goes up by 6% every 10 years of age. These individuals carry a 1%
annual risk of transformation to myeloid diseases such as myelodysplastic syndrome (MDS) and acute myeloid
leukemia (AML). Additionally, they are associated with increased risk of other important age associated diseases.
While CH is clearly a predisposing condition to MDS and AML, not all CH leads to myeloid disease. The factors
that promote CH progression to myeloid diseases remain to be elucidated. Mutations of TET2 are commonly
found in CH and the same mutations have been identified in myeloid malignancies, including MDS, chronic
myelomonocytic leukemia (CMML), and AML. Tet2 inactivation in mice leads to an indolent myeloid neoplasm
and the Tet2 knockout (KO) mice exhibit enhanced HSC self-renewal at the stage when the mice show no sign
of blood disease, therefore recapitulating many key features of CHIP. Our preliminary studies showed that high
fat diet (HFD) exposure in Tet2 knockout mice lead to dysregulation of HSPCs and accelerates myeloid
expansion, extramedullary hematopoiesis, and the development of myeloid malignancies. We hypothesize that
high fat diet promotes leukemic transformation of clonal hematopoiesis. The main objective of this proposal is to
elucidate the mechanistic links between HFD and CHIP, using Tet2 KO model, to identify the mechanism
underlying the effects of HFD on clonal hematopoiesis. We will determine the HSPC and other hematopoietic
populations that are dysregulated by HFD in Tet2 KO. Our studies identified MHC-II signaling as dysregulated
in Tet2 knockout mice fed on HFD. We will elucidate the function of MHC-II signaling in Tet2 KO driven clonal
hematopoiesis. Our studies will establish a model of age-related clonal hematopoiesis and its progression to
myeloid diseases, and provide new insights into the mechanisms by which dietary factors interact with epigenetic
regulators in CH. The work may identify novel targeted strategies to risk stratifying and preventing progression
of CHIP to MDS and other myeloid neoplasms.

Public health relevance
PROJECT NARRATIVE: Clonal hematopoiesis (CH) has recently been discovered to be a premalignant condition that predisposes patients to developing malignancies like acute myeloid leukemia (AML) and myelodysplastic syndrome (MDS). The mechanism by which CH transforms to MDS or AML remains unclear, and there are no curative treatment options available for these conditions other than stem cell transplant which carries significant toxicity and mortality. My study will establish high fat diet (HFD) as an important factor to promote CH progression to blood cancers, and provide proof-of-concept that targeting HFD-induced pathways may be therapeutically beneficial to prevent onset of severe blood diseases.